Impact of Randomized Payment Incentives on Disparities in Home Dialysis and Kidney Transplantation

Kidney failure is a life-threatening condition that disproportionately impacts Black, Hispanic, Native American and low-income populations. Approximately 88% of patients with kidney failure initiate hemodialysis treatment, where in-center care typically requires thrice-weekly treatments and a permanent bloodstream catheter that predisposes patients to infectious and vascular complications. Alternatives to in-center hemodialysis include kidney transplantation, which is associated with lower mortality and improved quality of life, and home dialysis, which is associated with lower costs and can offer greater flexibility and independence. But these treatments are substantially underused, and substantial and persistent racial disparities have been documented in receipt of home dialysis and in all steps leading to transplantation. In January 2021, the Centers for Medicare and Medicaid Services (CMS) initiated the End-stage Renal Disease Treatment Choices (ETC) Model. This mandatory model – the first of its kind – randomly assigned dialysis facilities and managing clinicians in 30% of the US to receive financial incentives to increase rates of home dialysis and kidney transplantation. Although observational studies suggest that payment incentives may increase home dialysis, causal evidence is lacking, and no evidence exists on the impact of payment reforms on disparities in kidney failure treatments. More broadly, CMS and other payers have advanced value-based payment policies to improve quality of care, but evaluations of these strategies have been hampered by the absence of appropriate control groups, often due to uniform policy implementation across the U.S. Further, value-based payments may inadvertently lead to increasing disparities in access to care if safety-net providers have fewer resources to respond to performance incentives, or if performance measures fail to account for patients’ social risk. This proposal will test the hypothesis that although the ETC Model will increase home dialysis and referral/evaluation for transplantation, it will also widen disparities in these outcomes because facilities that disproportionately serve low-income patients will make lower performance gains and will be more likely to receive financial penalties. Our specific aims are: 1. Examine the impact of the ETC Model on the use of home dialysis and racial/ethnic and socioeconomic disparities in home dialysis, 2. Identify the effects of the ETC Model on disparities in access to kidney transplantation and 3. Examine consequences of the ETC Model for dialysis facilities according to their patients’ social risk. The proposal is innovative, as we leverage an unprecedented randomized payment reform to estimate causal effects of financial incentives on disparities for a high-cost, high-need population. We will derive neighborhood socioeconomic characteristics by geocoding patient addresses and maximize the comprehensiveness of our evaluation by including patients who lack traditional Medicare coverage. Thus, this work will provide rigorous, causal evidence about the impact on health disparities for one of the largest randomized tests of payment reform ever conducted in the U.S.

Public health relevance
Home dialysis and kidney transplantation are effective treatments for kidney failure, but they are underused, particularly among Black, Hispanic and Native American populations and those with low income. In 2021, the Medicare program implemented payment incentives to increase access to these treatments in a randomly selected 30% of regions across the US. This project examines the impact of these pay-for-performance incentives on racial, ethnic, and socioeconomic disparities in home dialysis and access to kidney transplantation.